The Role of Amino Acid Starvation Response Kinase GCN2 in Abdominal Aortic Aneurysm

Project Summary: Abdominal aortic aneurysm (AAA) is a life-threatening disease that afflicts ~1.5 million
Americans, particularly in the elderly populations. Despite its high mortality (80-90%) upon rupture, there is a
lack of effective drug therapies for clinical management of AAA. Surgical repairs remain the only effective
options; however, not only are they considered traumatic and risky, but also not indicated for the majority of
newly diagnosed AAA patients. Therefore, there is a pressing unmet need to develop non-surgical strategies to
contain AAA progression. Dietary restrictions of amino acids emerge as promising avenues to combat
cardiovascular diseases. For the first time, our study demonstrated the potential of dietary methionine or
leucine restrictions in inhibiting the development of AAA in a rat model. It is well established that such dietary
restrictions trigger the amino acid starvation response, a potent protective mechanism driven by the metabolic
stress kinase general control nondepressible 2 (GCN2). Indeed, in our preliminary study, silencing GCN2 in rat
abdominal aorta nullified the benefits of methionine restriction against AAA, suggesting a protective role of
GCN2 in reinstating aortic homeostasis. Activating GCN2 through methionine restriction protected smooth
muscle cells (SMCs) from undergoing degeneration, which is one of the key determinants of AAA
pathogenesis; conversely, reduced GCN2 activity was robustly observed in clinical specimens of AAA, and
GCN2 silencing effectively compromised the protection against SMC degeneration. Finally, we serendipitously
identified GCN2 to be citrullinated by peptidyl arginine deiminase 3 (PADI3) at its 1475 arginine (R1475)
residue in the starvation-sensing domain. This post-translational modification (PTM) of GCN2 was increased in
AAA and correlated with repressed GCN2 activity. Collectively, these preliminary results lead to our central
hypothesis: GCN2 plays a pivotal role in protecting against SMC degeneration and AAA formation, and its
activity is negatively modulated by PADI3-mediated citrullination; GCN2-activating strategies offer a new
paradigm for effective prevention and intervention of AAA. In Aim 1, we will dissect the role of GCN2 in
safeguarding SMC homeostasis as well as its downstream signaling using human and murine SMCs. In Aim 2,
we will characterize a new PTM regulation that negatively modulates GCN2 activity and delineate the biological
consequences of GCN2 citrullination in SMC. In Aim 3, we will determine the mechanistic and therapeutic
implications of GCN2 activation in AAA, utilizing both transgenic (SMC-specific GCN2 knockout mice) and
dietary intervention approaches (methionine restriction for treatment of pre-existing AAA lesions). The
successful completion of the proposed studies will not only uncover an intrinsic protective mechanism against
SMC degeneration and AAA pathogenesis, but also may provide a new paradigm through GCN2-activating
dietary restrictions for effective prevention and intervention of AAA.

Public health relevance
Narrative: Abdominal aortic aneurysm (AAA) is a life-threatening disease that afflicts ~1.5 million Americans. The progressive dilation of AAA culminates in its fatal rupture, yet there are still no effective therapies other than the risky surgical repairs. For the first time, our study discovered the therapeutic potential of dietary restrictions of single amino acid in preventing AAA in rodents. We further identified a molecular “brake” triggered by such dietary intervention and hence exerted its protection against AAA. The ultimate outcome of this project will lead to the establishment of new paradigms for AAA treatment — through dietary intervention or even drug therapies to activate this molecular “brake”.